A National Curriculum in Cancer Genomics for Physicians and Medical Students

Abstract
Genomic testing has become integrated into cancer care. Physicians routinely order tumor sequencing
analyzing hundreds of genes to identify options for personalized treatment. Unfortunately, there is evidence
that members of the oncology clinical care team may not have the knowledge and skills to effectively utilize
genomic data. Pathologists play a key role in tumor genomic testing and, since 2012, the Training Residents in
Genomics (TRIG) Working Group, a multi-organizational committee, has developed and implemented a
national pathology resident cancer genomics curriculum. Using a similar model, the Undergraduate Training in
Genomics (UTRIG) Working Group has developed a medical student curriculum. Through NCI R25 funding,
there has been remarkable progress with over 50 innovative international team-based learning (TBL)
workshops for over 2000 participants, creation of online resources and novel use of national resident in-service
exams to gauge progress in genomics curriculum implementation. To continue to ensure adequate pathology
resident and medical student cancer genomics education, and given the rapidly changing field, a major aim of
this grant renewal application is to revise, evaluate and further promote the TRIG and UTRIG curricula through
annual workshops including distribution of enduring materials. Another major proposed objective is to adapt the
TRIG model to a critical group of cancer care providers, oncology fellows. Working with the American Society
of Clinical Oncology (ASCO) and their Oncology Training Program Committee, oncology fellowship program
directors partnering with local site genomic oncology experts will be taught, through annual train-the-trainer
sessions, how to implement an expert-developed genomic oncology fellow curriculum. The program directors
will then implement the curriculum with their fellows with support from an online community platform. A
structured and rigorous evaluation process will allow continued improvement of the pathology resident, medical
student and oncology fellow curricula and workshops.

Public health relevance
Project Narrative Genomic testing has become integrated into cancer care and physicians routinely order tumor sequencing analyzing hundreds of genes to identify options for personalized treatment. As almost every physician will treat patients with cancer or cancer survivors and assist in cancer prevention and risk assessment, all require some knowledge of cancer genomics. Education beginning in medical school and continuing through training is needed to allow physicians to appropriately utilize genomic test results in the care of patients.